Administrative Core

PROJECT SUMMARY – CORE A, ADMINISTRATIVE CORE
The Administrative Core, will build on an established research center administrative architecture to support the
proposed BioSystems Networks and Translational Research center-Investigating Inflammation (BioSNTR-II).
This infrastructure includes an effective and proven administrative team that will coordinate fiscal and scientific
management across South Dakota State University (SDSU) and partner institutions. The Administrative Core
will support the development and transition to independence of each project leader through mentorship, efficient
research administration, development of resources, and support of professional career development. This core
will focus its efforts on fostering a supportive and collaborative research environment and culture intent on
advancing biomedical research at SDSU. These activities will include organizing monthly seminars and speaker
exchanges, annual research symposia, all center-associated travel, workshops, and training opportunities.
Additionally, the Administrative Core will manage and oversee a pilot project program to promote the
development of new center research projects. All BioSNTR-II resources including the development of each of
the research support cores will be coordinated by the Administrative Core to ensure financial and personnel
needs are met and newly developed tools and techniques are appropriate for use by the COBRE research
projects. Finally, the Administrative Core will work with both the SDSU administration and implement
recommendations from the External Advisory Board to conduct constructive evaluations of the research projects
and cores, overall development of the center, and faculty development goals. This core has experienced
personnel, established operating procedures and policies, and the thorough evaluation and review structures
necessary for the effective implementation of BioSNTR-II.